Genetic Control of Myelination by EGR2 and NAB proteins

DESCRIPTION (provided by applicant): Formation of the myelin sheath is critical for rapid conduction of nerve signals in motor and sensory nerves. The EGR2/Krox20 transcription factor is a master regulator of the myelination program in peripheral nerve, and human genetics studies have identified several independent EGR2 mutations associated with myelination disorders such as Charcot-Marie-Tooth (CMT) disease and Dejerine-Sottas Syndrome, which constitute one of the most common types of human genetic diseases. Although EGR2 expression correlates with induction of many myelin-associated genes, very few direct targets of EGR2 activity have been identified, and interactions with other myelin-specific transcription factors remain relatively obscure. Novel techniques outlined in this proposal will analyze interaction of EGR2 with other transcription factors during myelination in vivo to address the following specific aims: To determine if EGR2 interaction with a conserved intron-associated element regulates Myelin Protein Zero expression. Myelin Protein Zero (MPZ) is one of the most highly expressed myelin genes, and is commonly mutated in peripheral neuropathies. This proposal will probe the mechanism by which EGR2 activates a newly discovered control element in the MPZ gene, and will elucidate the mechanism by which dominant EGR2 mutants cause disease. To test the role of EGR2/SREBP synergy in regulating myelination. This aim will explore the scope and mechanism by which EGR2 collaborates with Sterol Response Element Binding Proteins (SREBPs) to activate genes required for the myelination program. . To test the role of CHD4 in regulation of EGR2 target genes by NAB proteins during peripheral nerve myelination. This aim will provide the first mechanistic analysis of NAB repression of EGR2 target genes by investigating the role of the NuRD chromatin remodeling complex. Deficiencies in formation of the myelin sheath around nerve fibers are a central cause of several important medical disorders, including many types of muscular dystrophy, diabetic neuropathy, multiple sclerosis, and leprosy. Formation and maintenance of lipid-rich myelin is a complex process, and this proposal is directed towards understanding genetic control of the myelination process in the peripheral nervous system. These experiments will provide novel insights that will be vital for development, evaluation, and implementation of novel therapies for these diseases. .